New insights into early T cell protection during acute toxoplasmosis

Project Summary/Abstract
Toxoplasma gondii is an opportunistic protozoan pathogen widespread in humans, domestic animals,
livestock and wildlife. The parasite is known for its ability to trigger a strong inflammatory immune response
that is effective in protecting the host from infection, but that can nonetheless sometimes cause severe
immune-mediated tissue damage. The long-term objective of this proposal is to understand the basis of
innate and acquired immune responses that protect against infection with T. gondii and other microbial
pathogens. Our preliminary data in mouse models of infection reveal aspects of early T cell immunity to
Toxoplasma that have not previously been recognized, despite many decades of past research. Infection with
cps1-1, a normally replication-defective Toxoplasma strain, elicits an early protective CD4+ and CD8+ T cell
response that requires neither IL-12 nor Toll-like receptor adaptor MyD88, that only partially involves IFN-g,
and that is essential to prevent this parasite strain from behaving in a virulent manner. The goal of the project
is to understand the function of these T cells in protection against Toxoplasma. The central hypothesis
driving the research is that the T cells elicited by infection display novel mechanisms of activation and anti-
microbial function. Three specific aims will evaluate the hypothesis. Aim 1: Determine whether cps1-1-
induced T lymphocytes function in a conventional or nonconventional antigen-specific, MHC-restricted
manner. We will employ adoptive transfer approaches to determine if parasite-induced T cells act in a classical
MHC class I and MHC class II restricted manner involving cognate antigen. Aim 2: Determine the
transcriptomic profile and activation phenotype of cps1-1-induced CD4+ and CD8+ T lymphocytes. RNA-seq
will be used to identify the underlying properties displayed by the cells necessary for protection. Aim 3: Identify
effector mechanisms controlling cps1-1 infection. We will determine how two T cell mediators, CD154 and
perforin, act with IFN-g to control infection employing an adoptive transfer approach along with gene knockout
mice. The importance of this research is that we stand to reveal previously unrecognized aspects of immunity
to Toxoplasma. This can be expected to impact our understanding and ultimately ability to treat infection with
Toxoplasma and other microbial pathogens.

Public health relevance
Project Narrative/Relevance The relevance of the project to public health is that it deals with host immune responses and inflammation during Toxoplasma gondii infection. This parasite is classified as a class B biodefense pathogen. Toxoplasma is a common opportunistic infection in humans that can cause life-threatening disease in immunocompromised populations and in congenital infection. Completing the project may ultimately identify new targets to treat inflammatory disease and to improve immunity to microbial infection.